Assessing the Risk of SARS-CoV-2 Remdesivir Resistance

PROJECT SUMMARY
The rapid spread of the SARS-CoV-2 pandemic around the globe has led to an urgent and ongoing evaluation
of therapeutic strategies for the treatment of Coronavirus Disease 2019 (COVID-19). While a handful of host-
directed therapies are being used for the treatment of severe disease, including monoclonal antibodies and
dexamethasone, there is only one antiviral with emergency use authorization, the nucleotide analog remdesivir
(GS-5734). Remdesivir is thought to inhibit the viral RNA-dependent RNA polymerase, Nsp12, through
nucleotide mimicry and early chain termination. As use of remdesivir for the treatment of COVID-19 escalates, it
is essential to understand the nature and risk of developing antiviral resistance. We hypothesize that intra-host
variation in Nsp12 could allow for the evolution of remdesivir resistance. In this exploratory grant, we propose to
test this hypothesis by quantifying the SARS-CoV-2 viral diversity that arises in hospitalized patients over time
with and without remdesivir treatment (Aim 1), and by determining the impact of known Nsp12 mutations on
polymerase activity and sensitivity to remdesivir (Aim 2). In Aim 1, we will leverage a biobank of longitudinally
collected nasopharyngeal swabs from hospitalized COVID-19 patients at Northwestern Memorial Hospital.
Specimens were collected every 4 days after enrollment for up to one month, including specimens from 8 patients
given remdesivir. We are continuing to collect specimens and intend to enroll an additional 50 COVID-19 patients
over the coming months. Deep, whole genome sequencing of SARS-CoV-2 viruses from each specimen will be
performed to classify the viral variants detected within each patient over time. The nature and extent of variation
will be compared by time point, viral load, and treatment course as determined from medical record data. These
studies will be complemented with deep sequencing of viruses produced ex vivo in the presence of varying
concentrations of remdesivir. Overall, this work will determine the nature and extent of SARS-CoV-2 intra-host
variation that develops in hospitalized patients and will determine the impact of remdesivir treatment on that
variation. In Aim 2, in vitro oligonucleotide extension assays will be used to assess the impact of previously
described Nsp12 mutations on polymerase activity and remdesivir efficacy. Documented mutations near the
remdesivir binding pocket and Nsp12 active site, newly documented haplotypes arising in our patient population,
and Nsp12 mutants found to be under selective pressure will be assessed first for polymerase activity followed
by remdesivir sensitivity. The phylodynamic histories of impactful mutations and haplotypes will be followed to
look for evidence of selection in the population. Together, these results will assess the risk of emergent
remdesivir resistance and additionally identify potential resistance mutations for active monitoring.

Public health relevance
PROJECT NARRATIVE Remdesivir is currently the only antiviral drug authorized for emergency use in treating severe COVID-19. The goal of this study is to assess the risk of developing Remdesivir resistance by monitoring SARS-CoV-2 viral evolution and diversity in COVID-19 patient samples and biochemically characterizing known viral mutants near the Remdesivir binding site. Ultimately, this work will inform the use of Remdesivir for the treatment of COVID- 19 and will identify potential resistance mutations in SARS-CoV-2 for active monitoring.